N-glycosylation as a regulator of Grp94 Function and Activity

PROJECT SUMMARY
Most newly synthesized proteins destined for the cell surface or secretion must transit through the endoplasmic
reticulum (ER) for folding and post-translational processing. Grp94, the ER resident member of the hsp90
family of chaperones, is required for the maturation of various membrane and secreted proteins. Grp94's
control over the fate of these diverse clients makes it an emerging therapeutic target for a number of chronic
diseases including type 2 diabetes, familial hypercholesterolemia, and sepsis, as well as cancers such as
HER2-positive breast cancer and multiple myeloma. An unanswered question is how Grp94 adapts to different
needs within a dynamic ER folding environment to ensure efficient client capture and folding. Despite being
the most abundant protein in the ER, Grp94 is even further upregulated under conditions of cell stress or
disease. The increased overexpression of Grp94 correlates with its hyperglycosylation, the utilization of the five
minor glycosylation sites that are sparingly occupied in nonstressed cells and tissues. Recent studies have
shown that hyperglycosylation imparts new functions to Grp94 that are essential for the successful response to
stress or maintenance of the pathological state. Our central hypothesis is that differential glycosylation serves
as a tuning mechanism that alters the functional status of Grp94. A systematic analysis of the effects of
glycosylation on Grp94 has been hampered by the difficulty in producing site-specific, homogeneous
glycoproteins that would allow for the clear interpretation of functional and biochemical assays. Here we
propose to study how the activity of Grp94 is regulated by glycosylation and to visualize the capture of a client
protein. We will make use of a novel in-cell expression system developed in our lab that allows us to
selectively control the glycosylation patterns of Grp94 at all available sequons. We will employ these defined
glycosylated species in both in vivo and in vitro Grp94-specific assays that allows for the interrogation of Grp94
activity as a function of attached glycans. Combined with structural and biochemical tools, we expect to
determine how glycosylation regulates the structure and function of Grp94 and how a client protein is captured
by the chaperone.

Public health relevance
PROJECT NARRATIVE Our study focuses on a multi-component switching mechanism that changes the activity of Grp94 from a normal folding chaperone to a disease specific variant that helps cancer cells survive. We introduce a new method of separately studying the individual elements of this switching mechanism, and use this technology to dissect how each component alters the function of the chaperone. Our overarching goals are to discover how this switch changes Grp94 and to use this knowledge to distinguish between the pathologic and normal forms of Grp94 so that the first can be targeted for treatment while second is spared.